Accelerating the translation of oligonucleotide therapeutics by enhancing delivery

ABSTRACT
Oligonucleotide therapeutics (ONTs) are poised to ignite a paradigm shift in what constitutes a “treatable”
human disease. The FDA approval of life-changing ONTs like Spinraza (Ionis’ ASO therapy for spinal muscular
atrophy), Onpattro (Alnylam’s siRNA therapy for hATTR amyloidosis), and the mRNA-based COVID-19
vaccines from Pfizer and Moderna that saved millions of lives demonstrate the profound potential impact ONTs
can have on “undruggable” diseases. CRISPR-based editing strategies are now entering the clinic, with lipid
nanoparticle-mediated delivery of mRNA encoding Cas9 variants offering an alternative to problematic viral
vectors. Suppressor tRNAs that read through premature stop codons to restore proteins that were “lost in
translation” are moving towards the clinic. Each of these ONTs faces a shared barrier to broad clinical
translation: biological membranes. The large size (5-35 kD) and charged backbone of ONTs severely limits
their ability to cross the plasma membrane. Even if the plasma membrane is crossed by promoting the
endocytosis of the ONT, the endosomal membrane remains a highly effective barrier that prevents ONTs from
reaching their targets in the cytosol and nucleus. Estimates are that only 1-3% of the ONT delivered to a
patient reaches its target - the delivery stats are dismal for naked, ligand-conjugated, and LNP-encased ONTs.
ONTs tend to accumulate in the liver, and most FDA-approved ONTs that are delivered systemically have liver
targets. ONT conjugation to GalNAc, the ligand for the asialoglycoprotein receptor expressed on hepatocytes,
improves delivery 30-fold. Other approved agents rely on local delivery to increase ONT exposure to a level
sufficient to provide clinical value. However, not all tissues are suited for local delivery, many cell types with
these tissues remain inaccessible to ONTs, and local delivery risks infection or damage to the target organ.
There is thus a critical unmet need for strategies that improve the delivery of systemically administered ONTs
to extrahepatic tissues. Until this need is met, a revolution in medical practice ushered in by nucleotide-based
therapies will remain a dream unrealized. This proposal seeks a small molecule solution to the delivery
problem. This strategy would be effective for multiple ONT platforms and disease agnostic. By drilling down on
rigorous target validation from the outset, we hope to initiate a successful drug development program that
takes the most direct path to the clinic. Our lead compounds diverge from status quo potentiators in that they
dramatically increase ONT activity without causing endosomal damage, an effective, but prohibitively toxic,
mode of action. The expected results would provide a solid foundation for funding a successful lead
optimization program supported by target engagement assays and highlight the diseases most likely to rapidly
realize the benefits of this approach.

Public health relevance
NARRATIVE In principle, oligonucleotide therapeutics could be used to treat virtually every human disease. However, the broad use of these next-generation therapies is currently limited by the very low efficiency with which they cross cellular membranes. The goal of this project is to identify protein targets for small molecules that significantly enhance the delivery of many different oligonucleotide therapeutics while avoiding the toxicities that have plagued this strategy in the past.